Randomized Trial of a Novel Approach to Addressing Fear of Progression in Advanced Cancer

ABSTRACT
Precision oncology has led to a growing population of adults with advanced cancer living increasingly longer
lives in the face of profound uncertainty about the future, with over half reporting moderate to high fear of cancer
progression (FoP)—anxiety about the high risk or certainty of disease progression. These fears are associated
with anxiety and depression, over-use of healthcare, physical symptom burden, higher treatment regret, fatigue,
and, in many studies, poorer quality of life. Moreover, FoP is strongly correlated with cancer-related trauma
symptoms—physical hyperarousal, intrusiveness of cancer-related thoughts/images, and avoidance of cancer-
related thoughts and feelings—which are associated with similarly poor outcomes, suggesting overlapping
symptoms and etiology. While behavioral interventions exist to target fear of recurrence in early-stage cancer
survivors, there is a notable dearth of behavioral interventions to address FoP or cancer-related trauma
symptoms in adults with advanced cancer, and no known published randomized trials of such interventions in
the United States. This represents a critical gap in knowledge for the growing community of advanced cancer
survivors. In addition, cutting-edge developments for the treatment of trauma in general populations have not
been adapted to cancer populations. To address these gaps, we adapted a cutting-edge behavioral treatment
for trauma to reduce FoP and cancer-related trauma symptoms among adults with advanced cancer. The
intervention, titled EASE, is based on written exposure therapy, a highly efficacious approach for reducing trauma
symptoms in general populations that is better accepted and far briefer than other gold-standard approaches.
EASE adapts this effective approach to help advanced cancer patients with elevated FoP and cancer-related
trauma symptoms to reduce their fear of the future by using written exposure focused on their future worst-case
scenario with cancer. Informed by the NIH stage model, we evaluated EASE delivered by telehealth in an open
pilot trial for 29 adults with late-stage cancer and elevated FoP and cancer-related trauma symptoms. Pilot
findings show strong acceptability, feasibility, and efficacy potential. We now propose to conduct the first
randomized trial of EASE, and, thus, first known randomized trial in the United States of a behavioral intervention
for FoP and cancer-related trauma symptoms among adults with advanced cancer. Across both community and
academic cancer clinics, this 2-arm trial (N=250) will compare EASE delivered by telehealth with Usual Care
(UC), with 1:1 randomization. We aim to compare EASE to UC on FoP and cancer-related trauma symptoms
(primary outcomes) and anxiety, depression, hopelessness, and quality of life, at post-intervention (Aim 1) and
follow-up (Aim 2). We also will evaluate theorized mechanisms for EASE relative to UC (Aim 3). Offering EASE
in both English and Spanish, and by telehealth, increases access. Simple content increases scalability. Rigorous
evaluation of EASE has the potential to provide a paradigm-shifting intervention ready for dissemination and a
solid empirical foundation to inform evidence-based care guidelines for distressed adults with advanced cancer.

Public health relevance
PROJECT NARRATIVE In the era of precision oncology, many adults diagnosed with advanced cancer are living longer but with profound uncertainty about the future; over half report moderate to high fear of cancer progression (FoP). However, no known large, published, randomized trials in the U.S. have evaluated a behavioral intervention that targets FoP among adults with advanced cancer, or cancer-related trauma symptoms, which frequently co-occur with FoP. Building on a promising novel intervention we developed and piloted, the proposed study provides the first such randomized trial for FoP and cancer-related trauma symptoms among U.S. adults living with advanced cancer.